DARSaW: Developing, Assessing, and Refining Synthetic Sampling Weights to Improve Generalizability of the All of Us Research Program Data

Project Summary
The All of Us Research Program (All of Us) is a large-scale initiative to collect and study
multimodal data from over one million participants living in the United States (U.S.). Studies
have shown significant disparities in disease prevalence compared to the broader U.S.
population, potentially due to the overrepresentation of traditionally underrepresented groups.
The challenge that limits the representativeness of All of Us to the target U.S. population is that
the data are collected through a non-probabilistic sample design. This proposal aims to leverage
two types of external data resources from the U.S. population to construct reliable Synthetic
sampling Weights (SaW) for All of Us to mimic a probabilistic sample design and improve
generalizability. The first external data resource, National Health and Nutrition Examination
Survey (NHANES), creates a nationally representative dataset with validated sampling weights
and individual-level data made publicly available. However, NHANES’ sample size is relatively
small and can result in under-coverage. The second external data resource, the U.S. Census
and the American Community Survey (ACS), are large-scale nationwide surveys that provide
more but aggregated demographic and housing information about the U.S. population,
compensating for the limitation of NHANES. However, individual-level data are not available.
Utilizing the external data resources available in NHANES, the U.S. Census, and ACS, this
project will develop, assess, and refine Synthetic sampling Weights (DARSaW) to improve the
generalizability of All of Us to the target U.S. population. In Aim 1, we will develop the SaW for
All of Us by leveraging the individual-level data from the NHANES and rich but aggregated
summary statistics from the U.S. Census and the American Community Survey. In Aim 2, the
effectiveness of the SaW will be assessed through case studies, comparing unweighted and
SaW-weighted estimates of obesity, hypertension, and disability. We will iterate between Aims 1
and 2 to refine SaWs at the presence of discrepancy by post-calibrating to broader and deeper
aggregated statistics from the target population. The goal of this proposal is to demonstrate the
ability of the SaW to improve the generalizability of the All of Us data, enabling researchers to
draw valid conclusions about the target U.S. population.

Public health relevance
Narrative The All of Us Research Program aims to collect data from a diverse group of participants in the United States with an overrepresentation of traditionally underrepresented groups. However, there are disparities in disease prevalence compared to the broader U.S. population, limiting the ability of researchers to test hypotheses that could apply to the U.S. population. To improve the generalizability of the data and expand their impact, this proposal aims to develop, assess, and refine synthetic sampling weights for the All of Us Research Program data by leveraging external data resources from the U.S. population.